NIH StrokeNet- Regional Coordinating Stroke Centers for year 2023

PROJECT SUMMARY / ABSTRACT
The objectives of this proposal are to enhance the successful mission of Georgia Stroke Net by accelerating recruitment into NIH Stroke Net clinical trials for patients with acute stroke, people at risk for recurrent stroke, and individuals recovering from stroke. To enhance the implementation of practice changing research in stroke, the Georgia Stroke Net team will propose new and innovative clinical trials in the areas of acute stroke treatment, secondary prevention of stroke, and rehabilitation after stroke to be conducted within the NIH Stroke Net. We also propose to provide training opportunities for promising young investigators interested in clinical stroke research as a career and implement a career development program for research managers and coordinators. As a currently funded NIH Stroke Net Regional Coordinating Center (RCC), the Georgia Stroke Net brings an established infrastructure of highly successful and collaborative investigators and coordinators, with many years of proven expertise in designing, conducting, and enrolling patients into randomized clinical trials across the continuum of stroke care, from pre-hospital through rehabilitation. Our RCC will continue to implement research protocols using master trial agreements and a central IRB, and bring strong leadership skills, as evidenced by our team members’ commitment to ongoing and future participation in NIH Stroke Net working groups to critically review trials and new proposals to be implemented in the network. We plan to leverage existing and new opportunities to expand our referral base and increase detection and enrollment of eligible patients from a diverse background into NIH Stroke Net trials. This approach includes utilizing our local and regional relationships within networks of providers to identify potential research subjects. We will expand Georgia Stroke Net’s collaborative team of experienced investigators, recruiters, and evaluators and create synergy across multiple research resources that include direct and in-kind contributions. We plan to submit new clinical trial proposals to the NIH that build upon our team’s expertise in acute stroke, prevention, and recovery. Emory’s Georgia Stroke Net proposal builds upon our RCC’s track record of nearly 10 years of highly successful participation as an NIH Stroke Net site and a 30 year history of high enrollment in multiple NIH and industry sponsored practice changing randomized clinical trials in stroke.

Public health relevance
PROJECT NARRATIVE Stroke is a devastating disease and a major public health burden in the US and worldwide. Evidence-based medical practice depends on rigorous scientific methods conducted in multi-center clinical trials. Funding for NIH Stroke Net Regional Coordinating Stroke Centers (PAR-17-276) provides a mechanism for developing, promoting, and conducting high-quality, multi-site clinical trials focused on key interventions in stroke prevention, treatment, and recovery.